Type III effector regulation of host signal transduction systems

Project Summary
Bacterial Type 3 Secretion System (T3SS) “effector” proteins are the primary virulence factors that guide
the progression of numerous Gram-negative bacterial infectious diseases. Recent studies have estimated that
a single pathogen delivers up to 250 unique effector proteins directly into host cells. Collectively, these
virulence factors suppress host innate immune responses and facilitate bacterial replication, dissemination,
and disease progression. Therefore, determining how bacterial effector proteins control host intracellular
communication pathways at the structural, biochemical, and cellular level is an ongoing challenge in infectious
disease research. This proposal seeks to reveal a structural and functional understanding of these host-
pathogen relationships. Prior to this proposal, we identified a class of bacterial E3-ubiquitin ligases that
protects the human pathogen Shigella flexneri from the innate immune system activation and execution of
bacterial lysis. Here, we will specifically examine the molecular mechanism for bacterial regulation of the
newly identified Gasdermin-family of mammalian pore forming cytolysins. This includes determining how
Gasdermins function to suppress Shigella flexneri at the molecular and cellular level (Aim 1). We will also
examine this host-pathogen interaction at atomic level resolution by solving the effector-Gasdermin structure
using X-ray crystallography (Aim 2). The resulting structure-based theories will be tested in murine models of
Gasdermin function that are designed to evaluate mucosal immune protection against a broad spectrum of
enteric pathogens (Aim 3). Developing new drugs that target bacterial effector – host enzyme complexes would
be an innovative approach to combat emerging infectious disease. While this idea holds great potential, the
paucity of mechanistic information gleaned from virulence factor structure/function studies has so far hampered
their development as suitable drug targets. As a means to this end, these studies will allow us to predict new
mechanisms of action for understudied Shigella effector proteins, and provide a glimpse into the structural-
based evolutionary progression of a related pathogen groups.

Public health relevance
Project Narrative Innate immune signal transduction pathways are major targets of bacterial toxins and effector proteins. This proposal examines the ability of a family of bacterial type III effector proteins to hijack human signaling enzymes. Gaining a deeper understanding of how these bacterial effectors hijack components of the host inflammasome using biochemistry, X-ray crystallography, and in vivo models will lead to a more complete knowledge of numerous pathogenic mechanisms and may reveal new aspects of signal transduction in the human host cell.